VoiceLove: NICU Utilization of Remote voice Technology to improve mateRnal Experience (NURTURE)

Postpartum depression (PPD) is the most frequent major depressive disorder following childbirth and is
associated with adverse outcomes and poor quality of life for the mother and child. Separation during the initial
postpartum period, such as infant admission to the neonatal intensive care unit (NICU), impacts maternal-
infant bonding and increases PPD risk by 40%. Feeling disconnected from their infant is a major risk
factor for NICU parents developing PPD. The sense of parents not feeling constantly connected to their
infants during a NICU stay, and low social support create a high emotional burden on the mother and her
partner. PPD risk is decreased when parents have more contact with their infant and a higher perceived social
support system. When physical contact is not possible, voice contact may help to foster feelings of
connectedness. The medical team is another critical source of social support that can alter parental mental
health. Mothers of infants in the NICU report increased depressive symptoms when their perception of nurse
support is low, while increased communication between parents and the medical team improves parental well-
being. Increased social support from loved ones and the medical care team could significantly reduce PPD
severity in parents of babies in the NICU. However, NICU units are primarily focused on infant care and are ill-
equipped to address parental mental health. Facilitating communication between parents and healthcare
providers, as well as between their friends and family, without increasing work burden for healthcare
providers could dramatically impact the mental health and well-being of parents during their baby’s
NICU admission.
VoiceLove LLC is developing a novel HIPAA-compliant mobile application that enables expanded family
engagement by providing an electronic venue for direct patient-family-provider interactions that mitigates
barriers to communication. The VoiceLove app is a safe and time-efficient tool for direct communication with
absent family members, allowing more time for direct patient care. A pilot study with ICU patients at New York-
Presbyterian Hospital demonstrated thousands of direct family messages exchanged without any additional
nursing burden. In this Fast-Track STTR, we will refine the VoiceLove prototype and evaluate the new
application among parents and NICU providers. Phase I will optimize the VoiceLove app for NICU families and
providers. Phase II will include a randomized control trial (RCT) comparing VoiceLove implementation to usual
care control to evaluate the impact of the VoiceLove app on maternal PPD scores and on patient-family-
provider communication and engagement. This Fast-Track STTR represents a major step forward in bringing a
novel technology to the NICU to expand family engagement, empower the clinical experience, and decrease
the prevalence of PPD.

Public health relevance
Postpartum depression (PPD) is a devastating complication of childbirth that can be exacerbated in mothers with infants admitted to the neonatal intensive care unit (NICU). Lack of infant and social connectedness increases PPD risk; however, NICU units are understaffed and ill-equipped to address parental mental health. VoiceLove LLC is developing a novel HIPAA-compliant mobile application that enables expanded family engagement by circumventing barriers to communication by allowing an electronic venue for direct parent- family-provider interaction.